Controlling Tumor Immune Escape in Pancreatic Cancer using a Dual T Cell Product Strategy

ABSTRACT
While T cell therapies have shown efficacy in hematologic malignancies, extension of this success to solid tumors
has proven to be challenging, mainly due to the immunosuppressive and hostile tumor microenvironment (TME).
Marker proposes to overcome the immunosuppressive TME by developing a secreted recombinant fusion
protein, DECOY. The purpose of the DECOY protein is to transform the immunosuppressive TME into one that
will support therapeutic T cell growth and function. We therefore propose a binary strategy for T cell therapy, as
a combination of two T cell products. Product #1 consists of DECOY-producing T cells that will be delivered to
the tumor and has the ability to alter the TME, making conditions more favorable for subsequent T cell therapy.
Product #2 is MT-601, our autologous multi-tumor associated antigen (mTAA)-specific T cell product that
recognizes 6 antigens present in pancreatic cancer cells. It has shown an excellent safety profile and initial
efficacy in a clinical trial in advanced or metastatic pancreatic cancer. The purpose of the combination of DECOY
with MT-601 is to further improve our initial clinical efficacy by protecting MT-601 T cells from the
immunosuppressive TME. The rationale for the binary delivery system is to maintain the safety profile of MT-601
T cells by separating the delivery of DECOY T cells. In essence, this strategy separates the fuel (DECOY) from
the engine (MT 601) driving anti-tumor activity, providing the operator with the ability to control the engine by
adding more or less fuel. This binary approach will overcome strategies implemented by the tumor to evade
immune surveillance. In this project, we will evaluate the kinetics and parameters to guide clinical application of
Product #1 (DECOY), determine the optimal clinical administration of Product #2 (MT-601) when combined with
Product #1 (DECOY), and perform GMP-compliant validation and engineering runs for clinical implementation
of the binary product strategy. Successful completion of this project will result in the amendment of our FDA-
approved MT-601 IND that will use a binary product strategy that uses DECOY (Product #1) to enhance cancer
killing capabilities of mTAA-specific T cells - MT-601 (Product #2) in pancreatic cancer. This application will
therefore pave the way towards clinical implementation of a binary product strategy to address an unmet clinical
need for pancreatic cancer patients. If successful, this binary strategy will allow for a faster extension to other
adoptive T cell therapies and/or cancer indications for the purpose of increasing cell product potency while
maintaining the safety profile.

Public health relevance
NARRATIVE Pancreatic cancer is the 3rd most deadly cancer in the US, with only ~11% of patients surviving more than 5 years. Cell therapies have shown great promise in blood cancers by targeted killing of cancer cells, however this has been less successful in pancreatic cancer due to the hostile environment surrounding the tumor. We propose a binary cell therapy for pancreatic cancer, consisting of one product which transforms the hostile tumor microenvironment enabling a second product to target and kill pancreatic cancer cells.